Enhancing Synaptic Autophagy for Neuroprotection in Alzheimer's disease

Synapse loss is an early event in Alzheimer’s disease (AD), which may explain some of the earliest cognitive
symptoms seen in these patients. Macroautophagy, herein referred to as autophagy, is a lysosome mediated
degradation pathway that plays a specialized role in the synapse and, thus, may be important for learning and
memory. Autophagy is also implicated in the pathogenesis of AD. The precise role of autophagy in AD is still
unclear, but there is evidence that autophagic processing of synaptic proteins is disrupted in the course of AD.
This proposal aims to investigate how AD-associated pathogenesis interferes with synaptic autophagy and if
specifically targeting synaptic autophagy can be neuroprotective in an AD mouse model. Aim 1 will utilize primary
hippocampal cell cultures derived from the APPNL-F/NL-F mouse model of AD to determine which step in the
autophagic processing of synaptic proteins is disrupted by AD-associated pathogenic changes. Aim 2 will
evaluate if optimizing synaptic autophagy by over-expressing the proteins Rab26 and/or Bassoon in the mouse
brain is protective in APPNL-F/NL-F mice. To pursue these aims, this proposal incorporates biochemical,
histochemical, cell biological, genetic, and behavioral approaches in mouse models and primary neuronal
cultures. The data collected will provide insight into how AD-associated pathogenic changes contribute to
disruption of synaptic autophagy, and if optimizing synaptic autophagy can be protective in AD.

Public health relevance
Alzheimer’s disease is the most common degenerative disease of the brain, yet treatment options are very limited. This project aims to investigate how Alzheimer’s disease disrupts the connections between brain cells, and if we can protect those connections to prevent worsening in an Alzheimer’s disease model. This project has the potential to identify new targets for the development of treatments that would slow the decline in brain function in this debilitating disorder.